Regulation of Odorant Receptor Gene Expression

DESCRIPTION (provided by applicant): The olfactory system is able to recognize thousands of odorants thus maintaining food consumption in humans. The ability to identify odors by humans is dependent on odorant receptors within olfactory neurons that line the nasal epithelium. This epithelium is under continuous cell division by a basal stem cell population that produces immature olfactory neurons, which then become mature olfactory neurons. Odorant receptors (ORs) are clonally expressed in immature olfactory neurons. The mammalian genome consists of ~1500 OR genes; these genes belong to the seven-transmembrane receptor superfamily. However, each allele of each gene is treated as a separate entity leading to ~3000 OR alleles to be expressed in a clonal (singular) manner by olfactory neurons. The ability for this singular OR allele expression is a multi-step manner. A critical step is the production of a functional OR protein. Olfactory neurons are found in domains within the epithelium such that a given olfactory neuron chooses (in general) between ~100 OR genes (~200 alleles). The selection process occurs in two-steps: one of ~200 alleles is chosen for expression (1st choice) within an immature neuron, followed by OR protein production, which is tested for functionality. Failure to produce a seven-transmembrane protein allows for the singular choice mechanism to choose another OR allele in that same immature olfactory neuron (2nd choice). If the chosen seven-transmembrane OR is unable to couple with the signal transduction machinery, then that olfactory neuron will fail to mature and die. The critical step in the expression of an OR gene is the initial choice of one OR allele within an immature neuron (1st choice). To date, it is completely unknown how this singular choice process occurs at a molecular level. Analysis of very small OR promoter regions (~300bp) have lead to the identification of two transcription factors that may play a role: an O/E-1 type binding protein and a homeodomain type biding protein. The identification of more candidate DNA binding proteins and their interactions is necessary to understand the singular choice process. This project fully exploits the small regulatory regions used to produce OR singular choice in immature olfactory neurons. In Aim 1, the most minimal OR control region will be defined in order to identify other candidate transcription factors. There are at least 10-15 different olfactory neuronal cell types each fated to express one of ~200 OR alleles. In Aim 2, two minimal OR promoters normally expressed in different olfactory cell types will be used to identify additional transcription factors. This will allow the understanding of how specific patterns within the olfactory epithelium are obtained. In Aim 3, a candidate homeodomain protein will be deleted within immature and/or mature neurons in order to determine its role on OR gene expression. In Aim 4, I will make every attempt to promote this work into publications and greater funding.

Public health relevance
PUBLIC HEALTH RELEVANCE: Gene expression is necessary for cells to function properly in the human body. The sense of smell is critically dependent on olfactory neurons that translate the chemical world to the brain. Olfactory neurons govern this odor recognition process through careful expression of odorant receptors. Loss of olfactory function leads to poor feeding in geriatric populations as well as higher incidence of food poisoning. Studying odorant receptor gene expression will give insights into how the olfactory system is put together and maintained throughout adulthood. Gene expression is necessary for cells to function properly in the human body. The sense of smell is critically dependent on olfactory neurons that translate the chemical world to the brain. Olfactory neurons govern this odor recognition process through careful expression of odorant receptors. Loss of olfactory function leads to poor feeding in geriatric populations as well as higher incidence of food poisoning. Studying odorant receptor gene expression will give insights into how the olfactory system is put together and maintained throughout adulthood. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS The mammalian olfactory system is responsible for detecting odorants in the environment and transposing this information to the neural circuits within the brain. This odorant detection scheme is governed by ~1500 individual receptors genes, representing 2% of all genes, the largest gene family in the mammalian genome. Odorant receptors (ORs) are expressed in a very unusual manner; each olfactory neuron expresses only a single OR allele of any given OR gene (singular OR gene choice). Therefore, natural polymorphism that accrue in OR genes, which likely modify the odorant binding of an OR are treated as separate genetic elements. This means that there are ~3000 separate genetic units for expression in a given olfactory neuron. The OR protein is not only the means by which odorants are detected, but also the mode by which the olfactory neuron matures and survives. Thus, how the OR is regulated during development is the critical step for an olfactory function. Without this function, an organism raised in the wild cannot properly identify odors and perishes. Though food is abundant for humans, the avoidance of rotten foods is an important mechanism for maintaining health. At present the process for singular OR gene choice is completely not understood. It is unknown what proteins lead to the activation of the OR gene nor has any plausible explanation been rigorously tested for how expression of a single OR allele is established. In addition, no in vitro system exists for the study of this singular gene choice process. I aim to use a novel approach for the study of singular OR gene choice, using in vivo mouse genetics. The mouse is by far the easiest mammal for genetic studies. Genetic manipulation of the mouse olfactory system has proven to be a fruitful approach to study olfactory development in part due to two factors: 1) loss of the sense of smell is not lethal in captive mice and much of olfactory development occurs postnatally, which allows for analysis outside of the womb. The expression of one OR allele per neuron appears to have several phases. First, a single OR allele is chosen for expression in a neuron (1st choice). Next, the OR allele attempts to express it's OR protein. Failure to make a proper OR protein (This functionality of an OR protein is not known as of now) leads to the expression of a second OR allele by that same neuron (2nd choice). In 2002 and again in 2005, my colleagues and I set up an in vivo paradigm for the identification of OR promoters. We established two OR minigenes that were templates for 1st choice expression and recapitulate their genomic counterparts. These ~9kb minigenes contain the OR coding sequence and are able to prevent "2nd choice". To further analyze OR promoters, we have set up a reduced assay to follow "1st choice" expression of ORs using only ~300bp of DNA surrounding several OR promoters. Within these 300bp "1st choice" OR promoters we have found two conserved motifs: one that is suspected to bind with the LHX2 transcription factor and the other to bind the O/E class of transcription factors. The overall goal of my new studies is the elucidation of the precise sequences that govern 1st choice OR gene expression using these small well-defined OR promoters. We will also characterize the role of the Lhx2 gene in the 1st choice process. Specific Aim 1: Determine the minimal control regions for OR promoters. I will make a series of in vivo reporter mice that will dramatically reduce the "1st choice" control sequences from 300bp to perhaps as little as 50bp. This sequence will serve as a template for high-resolution nucleotide mutations of potential DNA binding sites. Being able to abolish choice by single nucleotide mutations will provide templates for identifying choice specific transcription factors in protein purification assays. In addition, having the core choice elements will lead to making multimers of these elements aimed at characterizing the mechanism of choice. Specific Aim 2: Determine the modular organization for OR promoters. It is unknown if different OR promoters use completely different transcription factors for the generation of "1st choice" or variations in the DNA-binding strengths. Thus, I will make chimeric promoters between two OR genes expressed in different types of olfactory neurons. Identification of these 1st choice modifiers will lead to a better understanding of the different processes of OR gene choice. Specific Aim 3: Determine the role of the OR enhancer binding protein, LHX2 on OR gene expression. A previous deletion of the LHX2 protein in all cells of the mouse suggests it has a role in 1st choice. From this experiment it was not possible to determine if it is required in olfactory neurons. We will make a conditional Lhx2 mutation and delete it specifically from immature and/or mature neurons. It will reveal if the mechanism of 1st choice is constantly occurring in both mature and immature neurons or if it is a singular event occurring in immature neurons that is maintained by distinct mechanism in mature neurons. Specific Aim 4: Development of the PI. I would like to develop into a leading scientist in my field. I will seek out collaborations and mentoring with established PIs. These mentorships will help me become better at writing manuscripts and grant applications. Thus, leading to publications in top journals (e.g. Science and Nature). In addition, I will attend meetings and present my findings for scrutiny amongst my more established colleagues.